2023 Angiogenesis Gordon Research Conference and Seminar

Project Summary/Abstract
This Angiogenesis Gordon Research Conference (GRC), “Angiogenesis and angiostability in
development, disease and engineered tissues”, and the accompanying Gordon Research Seminar (GRS,
organized by and for trainees) “Harnessing developmental angiogenesis to instruct cell therapies and
regenerative medicine” are designed to address the underlying hypothesis that the vast heterogeneity of blood
vessels is underlain by unique molecular and cellular mechanisms ensuring their proper formation and stability.
A better understanding of how and why blood vessels of different organs, sizes, and morphologies grow and
maintain their architecture, despite being under unrelenting hemodynamic assault, is critical to inform
vascularization of engineered or regenerating tissues and to normalizing vascular malformations.
The goals of the conference are, therefore, to bridge existing knowledge and communication gaps
between researchers at all levels (students, postdocs, junior and senior scientists in academia and industry) who
study angiogenesis and angiostability and those focusing on vascular diseases, stem cell biology and disease-
associated vascular dysfunction, including cancer, cardiovascular diseases, and stroke. These fields have
recently developed paradigms, tools, and models to aid this goal, and this integration is predicted to move
science forward toward the timely translation of basic discoveries. A complimentary GRS pre-meeting will also
be included and will be organized by trainees and for trainees. The GRS will feature trainee work presentations
to facilitate networking, and provide them with a peer group as they transition into the main meeting.
The GRC Chair and Vice-Chair are two female scientists in the field with strong scientific track records
and substantial experience in the organization of international scientific meetings. The meeting goals will be
accomplished by bringing together a selected group of researchers (about 180 participants) at Salve Regina
University, Newport, Rhode Island, for a week from July 30 to August 3rd, 2023. The choice of this venue is based
on solid precedent, as this meeting has taken place every two years since 1995 and has proven an ideal setting
for the Angiogenesis GRC. The venue and meeting structure are designed to foster extensive discussion
in response to presentations of largely unpublished data and to promote informal networking through
shared meals and afternoon social activities. Invited speakers are chosen based on excellence in research,
topic, and willingness to engage trainees. Participants will specifically be selected to reflect the broad
demographics of scientists working in the field. Women currently comprise 53% of confirmed speakers and
discussion leaders. Overall, this GRC/GRS will foster lasting interdisciplinary interactions and collaborations
amongst NIH-funded and international vascular and stem cell biologists, between academic and industry
scientists, and will develop the next cadre of scientists at the intersection of these fields. The design of the
meeting will have a lasting impact as it tackles crucial questions in health and disease in angiogenesis research.

Public health relevance
Narrative The Angiogenesis Gordon Research Conference (GRC) “Angiogenesis and angiostability in development, disease and engineered tissues” will stimulate generation of new knowledge by providing a brainstorming opportunity for scientists probing basic mechanisms of blood vessel growth and stability in health and disease, as well as engineered tissues. This focused small meeting (about 180 attendees) is designed to foster networking and discussion - with an emphasis on the exchange of new unpublished data and ideas, including latest technologies - and to jump-start collaborations that will move the field forward and shift paradigms. An associated Gordon Research Seminar (GRS) organized by and hosted for trainees will promote the next generation of interdisciplinary scientists to address important basic science questions and health issues in vascular biology.